Functional Evaluation to Predict Lower Extremity Musculoskeletal Injury

DESCRIPTION (provided by applicant): The World Health Organization now recommends at least 60 minutes of moderate to vigorous intensity daily physical activity for children ages 5-17. With increased activity recommendations comes increased risk for musculoskeletal injuries. The National Federation of State High School Associations considers the preparticipation physical evaluations (PPE) a prerequisite to athletics participation, yet despite this recommendation there are no large-scale controlled trials confirming the effectiveness of the PPE. The recently updated PPE guidelines promote a functional aspect of testing by incorporating performance based tests designed to evaluate deficits in movement control for identification of increased predisposition for injury. Limitations exist concerning the best recommended functional test components, their ability to predict musculoskeletal injury, and effectiveness as compared to a traditional PPE. As a first step towards addressing this limitation, our preliminary data demonstrates that deficits in functional performance (i.e., balance, strength, and movement control) are able to predict lower extremity injury. To address the gap in the knowledge of the PPE musculoskeletal examination, we will utilize an innovative approach to develop a cost-effective and time- efficient F-PPE for use in clinical settings. We will utilize a national cohortof randomly recruited high schools currently participating in a large-scale prospective longitudinal injury surveillance study (High School Reporting Injuries Online-RIO project). By using our High School RIO injury surveillance system we will record injury occurrence on athletes from 20 high schools for one year to identify which F-PPE measurement(s) are best associated with injury risk and develop operational procedures for the F-PPE. Our primary hypothesis is that functional pre-participation physical evaluations (F-PPE) will better predict lower extremity injury than traditional musculoskeletal PPE. Aim 1 hypothesis is that asymmetry indices will provide improved positive predictive value during a standardized F-PPE operational procedure developed to predict lower extremity injury risk for individuals participating in organized high school sponsored athletics. Aim 2 will utilize the F-PPE operational procedure developed in Aim 1 for four consecutive years to establish the prediction capabilities of the F-PPE. Aim 2 hypothesis is that injury risk prediction performance of the F-PPE will provide increased predictive capabilities as compared to the traditional PPE musculoskeletal examination model for assessing lower extremity injury risk in high school-aged athletic participants. The proposed research is significant because it will help to understand the parameters of functional performance testing in the PPE and evaluate methods for improving risk prediction of musculoskeletal lower extremity injury.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed research is highly relevant to public health because the health benefits associated with physical activity for children are significant and well reported. Yet the millions of individuals of all ages who engage in recreational exercise and sport face potential short and long term limitations to their function and participation across the lifespan due to lower extremity musculoskeletal injury. Thus, the proposed research is consistent with NIH mission that pertains to the development of fundamental knowledge to extend healthy life and develop translational clinical research to help reduce the burdens of injury and disability. __SpecificAimsTextDelimiter__ 2. Specific Aims More than half of all high school students participate in school-sponsored athletics, surpassing 7.6 million in 2009/2010. Using the national High School Reporting Injuries Online- RIO" system our team developed, knee and ankle injuries have been identified as a significant risk in this population29-30,35,119,125, resulting in estimated U.S. annual costs of nearly $9 billion. For 35 years, the American Medical Association's Committee on Medical Aspects of Sports has recommended preparticipation physical evaluations (PPE) as a method to screen for individuals at risk of injury, and the National Federation of State High School Associations considers the PPE a prerequisite to athletics participation. Despite this long history and obvious need, there are no large- scale controlled trials confirming the effectiveness of the PPE. This proposal aims to address this significant scientific gap. Standard costs for PPE have been estimated to range from $15 to $150 per individual, incurring direct costs of approximately $100 million to over $1 billion annually. The PPE 4th Ed. (2010) identifies its primary purpose as promoting health and safety by "screening for conditions that may predispose to injury or illness". The traditional musculoskeletal examination portion of the PPE has been a two-minute orthopedic screen focused on general range of motion, strength, and joint laxity, but recently updated PPE guidelines promote "functional" performance-based testing to improve predictive capabilities for injury. However, it is unknown which functional performance tests best predict musculoskeletal injury and improve effectiveness over a traditional musculoskeletal PPE. Our preliminary data demonstrate that deficits in functional performance (i.e., balance, strength, and movement control) are able to predict lower extremity injury using functional tests that are cost-effective and time-efficient.33,106-107,109 Our primary hypothesis is that functional pre- participation physical evaluations (F-PPE) will better predict lower extremity injury than the traditional musculoskeletal PPE. We will utilize an existing national cohort of randomly recruited high schools currently participating in a large- scale prospective injury surveillance study (High School Reporting Injuries Online-RIO" project). Aim 1 will develop an integrated cost-effective and time-efficient F-PPE for use in clinical settings. We will record injury occurrence on athletes from 20 high schools for one year to identify which F-PPE measurement(s) are best associated with injury risk and develop operational procedures for the F-PPE. Aim 2 will utilize the F-PPE operational procedure on the same 20 schools that will be followed for four consecutive years to establish the prediction capabilities of the F-PPE. If our hypothesis is correct, identifying limb asymmetries using the F-PPE tests will prove more effective to determine musculoskeletal lower extremity injury risk than the traditional PPE. In addition, if we are incorrect with our hypothesis and the traditional musculoskeletal PPE is better than the F- PPE, then this will provide the first evidence for efficacy of the traditional PPE. Aim 1. Identify components of functional balance, strength and movement control tests that improve prediction of lower extremity injuries and develop a standardized F-PPE operational procedure Hypothesis 1: Asymmetry indices will provide improved positive predictive value during a standardized F-PPE operational procedure developed to predict lower extremity injury risk for individuals participating in organized high school sponsored athletics. Functional performance tests that assess lower extremity postural control, strength, and dynamic movement control will be collectively assessed to identify the specific parameters (e.g., cut-off values, percentile thresholds, and normalized asymmetry indices) that best assess risk for acute ankle and knee injury in physically active high school athletes. Aim 2. Determine the injury risk prediction value of F-PPE and compare to Traditional PPE Hypothesis 2: The F-PPE will be more predictive of lower extremity injury risk than the traditional musculoskeletal PPE in high school-aged athletic participants. We will use the standardized F-PPE measurements to develop discriminatory statistical models to predict the risk of acute ankle and knee injuries, and estimate the influence of each functional measurement on overall risk prediction. In addition, we will study changes in F-PPE measurements over time and their influence on injury risk. This study will create evidence-based guidelines and cost-effective, time-efficient tools for performing preparticipation physical evaluations that will allow identification of athletes at risk and intervene more effectively to prevent knee and ankle injuries. These advances will hopefully enable greater numbers of children to achieve the World Health Organizations recommendation of at least 60 minutes of moderate to vigorous intensity daily physical activity to promote lifelong health.